Psychophysiological Correlates of Cognitive Bias Modification in Intermittent Explosive Disorder

PROJECT SUMMARY/ABSTRACT
Intermittent Explosive Disorder (IED) is the only disorder in the DSM-5 for which the cardinal symptom is
recurrent aggressive outbursts. IED is a common and multidetermined mental illness, which, if left untreated,
has a chronic and debilitating course that often involves interpersonal, occupational, and legal consequences,
as well as adverse physical health outcomes. IED also is associated with a number of cognitive biases related
to socioemotional information processing. Over-attentiveness to threatening information (attention bias) and the
tendency to attribute hostile intent to others (interpretation bias) are known correlates of aggression more
broadly, and aggressive behavior in IED specifically. Additionally, hyperarousal of the autonomic nervous system
(ANS) following provocation has been demonstrated in aggressive individuals; however, this phenomenon has
not yet been investigated in IED, nor has it been linked with the biased cognitive processing seen in the disorder.
Understanding the biological correlates of such cognitive biases is crucial to developing an integrated
biopsychosocial framework for IED. Further, understanding the mechanisms of cognitive bias modification (CBM)
could advance targeted interventions for IED that address both cognitive and physiological dysfunction.
Leveraging an existing randomized controlled trial led by my primary sponsor, the present study proposes to
examine the relationship between cognitive (attentional and interpretive) biases and physiological reactivity
following provocation both before and after a CBM intervention among individuals diagnosed with IED. At pre-
treatment, both IED (n = 48) and non-aggressive personality disorder controls (PD; n = 48) will complete
computerized measures of attention and interpretation biases, along with an aggression-provocation task (TAP;
Taylor Aggression Paradigm), during which psychophysiological data (i.e., heart rate, respiratory sinus
arrhythmia and electrodermal activity) will be collected. Following the pre-treatment assessment, participants in
the IED group will be randomized into either (1) a four-week (8-session) computerized cognitive bias modification
intervention (CBM; n = 24) or (2) a dose equated computerized placebo control (placebo, n = 24). In the CBM
condition, the tasks are aimed at modifying the aforementioned attention and interpretation biases using
corrective feedback between trials, whereas in the placebo condition, corrective feedback will not favor “non-
hostile” responses, presumably leaving any existing cognitive biases unaffected. Post-treatment procedures will
be identical to those at pre-treatment, in which cognitive biases are again measured via computerized tasks, and
psychophysiological data are collected during the TAP. Results of this study will provide further insight into the
pathophysiology of reactive aggression, the efficacy of CBM interventions for IED, and the development of novel
interventions for IED that address cognitive and psychophysiological dysfunction that characterize the disorder.
A training plan was designed to develop the applicant's expertise in the conceptual and methodological areas
relevant to the proposed study and professional development toward becoming an independent researcher.

Public health relevance
PROJECT NARRATIVE Aggression is a serious worldwide public health concern and Intermittent Explosive Disorder (IED) is the only DSM-5 disorder for which recurrent and impairing aggression is pathognomonic. The proposed study aims to further clarify the pathophysiology of IED by examining the relationship between two fundamental correlates of the condition, cognitive biases and autonomic nervous system reactivity, both before and after a computerized cognitive bias modification (CBM) intervention program. Results of this study will have the potential to a) contribute to an integrated biopsychosocial framework of IED specifically and aggression more generally, b) evaluate the efficacy of the CBM program for IED, and c) provide the empirical foundation for more targeted treatments that address the biopsychological dysfunction seen in IED.